Cell Based Regeneration of Salivary Glands

DESCRIPTION (provided by applicant): The potential utility of adult stem or progenitor cells for repair of radiation-damaged salivary glands is high, but is currently only a theoretical solutin for patients suffering from xerostomia. There remain several critical obstacles that must be resolved before cell-based therapy for dysfunctional salivary glands can be moved into the clinical arena. These include the identification of appropriate donor cells, the technology for promoting implantation, and direct functional assays to assess the outcomes. We propose to address these issues, using the powerful and well-defined genetic tools available in mice for tracing cell lineages, and cell types. In combination with tunable hydrogel scaffolds, we will use known salivary gland progenitor cells to determine environmental and cellular cues required for their differentiation in vitro and in vivo. The hydrogels will be used to transplant cells into two opposite environments: regenerating atrophic glands, and damaged irradiated glands. The goal is to determine if the use of hydrogels can promote in vivo differentiation of transplanted progenitor cells. To resolve whether the transplanted cells can produce saliva, we propose to generate a mouse model expressing a tagged secretory protein. Because this tool identifies the cellular source of the secretion, it may also prove to be a critical model for evaluating ways to stimulate endogenous regeneration of damaged salivary glands. The successful completion of this project will establish a foundation for subsequent translational research to progress the technology into clinical applications.

Public health relevance
This application combines the tools of mouse genetics with recent advances in biomaterial engineering to ask two questions: 1) Can isolated progenitor cell populations be used to reconstitute functional secretory structures in a damaged salivary gland? 2) Does the introduction of progenitor cells into a dysfunctional gland induce endogenous repair and/or secretion? Until these critical questions are resolved, progress toward cell- based replacement therapy in human salivary glands cannot occur. The successful completion of this project may lay the foundation for subsequent translational research to take the developed technology into clinical applications.